Deciphering the role of mitochondrial/autophagy dysfunction in regulating inflammatory processes during AMD pathogenesis

Project Summary: Age-related macular degeneration (AMD) is the leading cause of blindness in the elderly
and is driven by multiple genetic and environmental factors that lead to severe loss of central vision. However,
no definitive treatment options are available for the dry form of the disease. Inflammation has been known to
play an important role in maintaining tissue homeostasis. However, a deregulated inflammatory response is
associated with tissue damage and the onset of several aging diseases, including AMD. Even though several
studies have demonstrated the role of inflammation in AMD pathogenesis, the underlying mechanism
controlling the inflammatory cascades, particularly driving the onset of chronic inflammation in AMD, still
remains unknown. We have recently reported the novel finding that in dry AMD patients9,10 and in a mouse
model of dry AMD, there is inflammation induction due to the activation of Akt2 signaling in the retinal pigment
epithelial (RPE) cells-the first cells affected in dry AMD. Importantly, Akt2 inhibition in this mouse model
reduced retinal inflammation and alleviated early RPE changes. Additionally, AMD patients also have
increased Akt2 levels in the macular RPE cells relative to controls. Therefore, to evaluate the role of Akt2
activation in RPE health and in retinal degeneration, we have generated RPE-specific Best1 (Akt2) constitutive
knock-in (KI) mice. These mice show a dry AMD-like phenotype, as evident from basal laminar deposits,
decreased ezrin expression, hyperpigmentation, and morphological alterations in the RPE, as well as
decreased retinal function. We propose to use this mouse model and iPSC-derived RPE from CFH(Y/Y)
[controls] and CFH(H/H) [AMD risk allele containing] donors as novel tools in this study for testing our central
hypothesis that “activation of Akt2 signaling in the RPE triggers mitochondrial/autophagy dysfunction
leading to oxidative stress and inflammation, which are critical factors in early AMD pathogenesis”. To
address this hypothesis, we propose the following aims: Specific Aim 1 (mentored phase): To test our
hypothesis that Akt2 overexpression in the RPE elicits mitochondrial/mitophagy dysfunction thereby inducing
oxidative stress; Specific Aim 2 (mentored phase): To test our hypothesis that activation of Akt2 in the RPE
drives retinal inflammation; Specific Aim 3 (independent phase): To test our hypothesis that the molecular
cascades associated with autophagy-mediated regulation of inflammation are critical in AMD pathogenesis.
The proposed study is significant because we will use a unique, state-of-the-art in vivo animal model and
extend our studies to human iPSC-derived RPE samples to investigate how inflammation contributes to vision
loss in AMD and develop strategies potentially leading to a new treatment modality for early, dry AMD.

Public health relevance
Project Narrative: The deregulation of autophagy and heightened inflammation has been implicated in dry age-related macular degeneration (AMD). This proposal will use a novel mouse model and human iPSC-derived RPE cells from controls and AMD risk allele containing donors to decipher a yet unknown role of the crosstalk between the autophagy and inflammatory processes in the pathogenesis of dry AMD. We envisage that the proposed studies will help to develop strategies, potentially leading to novel therapies for this disease, which has no treatment available at the moment.